Preclinical Characterization of CRAC Channel Inhibitors for the Treatment of Alzheimer's Disease

Vivreon Biosciences, LLC
4940 Carroll Canyon Rd. Suite 110
San Diego, CA 92121
[email]
Vivreon Biosciences – NIA SBIR #PA-20-272 – Administrative Supplements to Existing NIH Grants and
Cooperative Agreements; Notice of Special Interest (NOSI): Administrative Supplement for Providing Technical
and Business Assistance (TABA) Funding to SBIR/STTR Awardees (Admin Supp) Notice Number: NOT-OD-21-
062
Project Summary
Vivreon Biosciences is pleased to apply for NIA SBIR Supplement #PA-20-272 to develop intellectual property
protection for the preclinical candidate in our currently funded SBIR R44AG061995, “Preclinical Characterization
of CRAC Channel Inhibitors for the Treatment of Alzheimer's Disease”. Supplemental funding is urgently required
for intellectual property freedom-to-operate (FTO) analysis and patent filings.
The programmatic goal of R44AG061995 is to de-risk our novel Alzheimer’s therapeutic development candidate
to make this program an attractive investment opportunity for third-party investors and pharmaceutical partners.
To arrive at a highly promising patentable development candidate, our workflow involved rigorous lead
optimization and candidate selection studies. Vivreon medicinal chemists designed and synthesized new
chemical entities (NCEs) with calculated parameters suitable for a CNS drug, which were then tested in potency,
ADME, and DMPK assays. These efforts have yielded a candidate therapeutic that demonstrates drug-like
properties appropriate for further development. The Vivreon candidate therapeutic is orally bioavailable, highly
brain penetrant, and effective in mouse and human models of AD. TABA supplemental funding is urgently
required for technical and business services to support intellectual property protections.

Public health relevance
Vivreon Biosciences, LLC 4940 Carroll Canyon Rd. Suite 110 San Diego, CA 92121 [email] Vivreon Biosciences – NIA SBIR #PA-20-272 – Administrative Supplements to Existing NIH Grants and Cooperative Agreements Project Narrative Current Alzheimer’s disease (AD) therapies act on neurons only to alleviate symptoms of the disease without slowing disease progression. Vivreon Biosciences is developing a novel therapeutic to block pathogenic microgliosis by inhibiting microglial Ca2+ release-activated Ca2+ (CRAC) channel activation for use in the treatment of AD. Vivreon Biosciences seeks urgent supplemental Technical and Business Assistance (TABA) funding for intellectual property freedom-to-operate (FTO) analysis and patent filings to ensure intellectual property protection of its candidate neuroprotective therapeutic.